Screening Variants of Unknown Significance to Identify Pathogenic Variants of the Manganese Transporter SLC39A8

Project Summary/Abstract
Manganese (Mn) is a trace element essential for life. As a cofactor of many enzymes, Mn is crucial for many
biological processes in humans. On the other hand, excessive Mn causes neurological disorders, including
dystonia and parkinsonism. Mn transporters play a central role in maintaining Mn homeostasis by controlling Mn
flux across plasma and organellar membranes. Among them, a plasma membrane transporter belonging to the
Zrt/Irt-like protein (ZIP) family, SLC39A8 (or ZIP8), dominates Mn reabsorption from the bile (a major route for
Mn excretion). Loss-of-function (LOF) mutations of slc39a8 lead to systemic Mn deficiency and is associated
with a rare and potentially lethal genetic disorder, SLC39A8-Congenital Disorders of Glycosylation (SLC39A8-
CDG), due to the abolished activity of Mn-dependent galactosyltransferases. Till now, more than three hundred
slc39a8 mutations found in the human population have been documented, but whether these genetic variations
are pathogenic or benign is an unresolved problem due to lack of experimental data and poor performance of
computational approaches for functional prediction. We hypothesize that many variants of unknown significance
(VUS) have defects in Mn transport and cellular trafficking. To test this hypothesis, we propose to apply an ICP-
MS-based transport assay and flow cytometry-based trafficking analysis to screen most of the missense variants
of SLC39A8. In Aim 1, we will identify the SLC39A8 variants with impaired Mn transport function by developing
and applying an improved cell-based transport assay with greatly increased throughput to screen a library
consisting of nearly 300 variants. In Aim 2, we will identify the SLC39A8 variants with defects in expression
and/or trafficking to cell surface by applying the established flow cytometry-based analysis to the SLC39A8
variants with impaired Mn transport activity. The success of this project will provide critical evidence for improved
risk prediction and early treatment of the SLC39A8-CDG patients. Functional characterization of hundreds of
variants will also provide valuable data to elucidate the molecular basis of SLC39A8-CDG and to better
understand the transport and cellular trafficking mechanisms of this understudied metal transporter.

Public health relevance
Narrative The manganese (Mn) transporter SLC39A8 is a key player in maintaining Mn homeostasis in humans and loss- of-function mutations of SLC39A8 leads to a rare but potentially lethal genetic disorder, SLC39A8-Congenital Disorders of Glycosylation (SLC39A8-CDG). The proposed research in this project will systematically screen hundreds of documented variants of unknown significance (VUS) of SLC39A8 by using innovative high- throughput approaches to identify those with impaired Mn transport activity and intracellular trafficking. The knowledge gained from this project will provide valuable data for early diagnosis and intervention of SLC39A8- CDG and for a better understanding of the structure-function relationship of this understudied metal transporter.